Long-acting Stable Glucagons for Treatment of Hyperinsulinism

SUMMARY/ABSTRACT
In severe persistent hyperinsulinism (HI), repeated hypoglycemic episodes can ultimately lead to
permanent seizure disorders, learning disabilities, cerebral palsy, blindness and even death. Clinical
studies have demonstrated the effectiveness of both short-term and long-term treatment with
glucagon for severe forms of HI and continuous subcutaneous administration of glucagon has been
recommended both because of the potential improvement in patient outcome and high costs of
surgical intervention followed by long-term annual care costs. However, the instability of native
glucagon renders it inappropriate for chronic use in HI, and care-giver concerns about pump and
infusion-tube blockage for stable glucagon analogs creates both administration problems and
potential complications. In our redirected Phase II grant, we successfully discovered long-acting
solution stable glucagon analogs suitable for treating HI, which would eliminate these concerns. In
this Phase IIb project, we aim to further validate these lead analogs in HI mouse models, perform
large scale (gram level) GLP production of the lead candidates to support the necessary toxicology,
immunogenicity and formulation studies for an IND application. We also intend to pursue Orphan
Drug Designation (ODD) and Rare Pediatric Disease Designation (RPDD) prior to IND submission.

Public health relevance
NARRATIVE In our redirected Phase II grant, a series of novel long-acting glucagon analogues were designed, produced at milligram levels, and tested for in-vitro activity and in-vivo effectiveness in a mouse model of HI. We have identified several lead candidates with superior properties and differential PK/PD properties in these initial studies. In this Phase IIb proposal we aim to move these lead candidates toward IND through further validation, large scale (gram level) GLP production, toxicology and formulation studies, apply for orphan drug and rare pediatric disease designations and complete a regulatory package suitable for IND filing.